Computational analysis of transcriptome rearrangements in SARS-CoV-2

The COVID-19 disease illuminated the critical barriers in our knowledge of the coronavirus
lifecycle and evolution and their importance for developing novel drugs and vaccines. Our future
pandemic preparedness is a key area of efforts based on breaking those barriers with novel
approaches in the re-analysis of significant amounts of data accumulated during the pandemic
years. In this proposal, we will advance such approaches by developing computational tools for
identifying non-canonical junctions (NJs) in the coronavirus transcriptome.
As suggested by our current observations, such NJs seem to have been missed by currently
available tools, are likely to be relevant for human infection and may lead to novel coronavirus
proteins. We expect our proposed software to identify them reliably, to shed light on their
properties and to help generate hypotheses for identifying novel mechanisms of NJ generation.
Understanding these mechanisms may provide novel targets that could lead to efficacious
treatments or novel vaccines, improving the overall pandemic preparedness.
Our computational pipeline will be released in an open-source form to the scientific community,
so that it could be used and improved by other researchers for studying other viruses and
pathogens that may employ similar mechanisms of transcriptome rearrangements. This project
will significantly enhance the research capacity towards sustainable research excellence of an
urban campus of Rutgers-Camden. It will support active participation of graduate and
undergraduate students, and such involvement is likely to generate their interest and motivation
toward careers related to a biomedical field.

Public health relevance
The SARS-CoV-2 virus requires no introduction yet despite intense research, many aspects of its lifecycle remain unknown, including the formation of virus chimeric RNAs that may lead to novel proteins or changes in gene regulation, likely affecting physiology of infected cells. This project will develop computational tools to identify such RNAs in different variants of concern from 200,000 COVID-19 patient samples and to develop mechanistic hypotheses on chimera formation and their effects on disease. It could lead to the development of novel diagnostic tests (potentially predictive of disease severity), preventive measures and treatments, improve our future pandemic preparedness against viruses and other pathogens.